Suppressors of Cytokine Signalling (SOCS) have Neuroprotective Roles in Retina

In this study we have investigated the involvement of SOCS proteins in regulating ocular inflammatory diseases of infectious or autoimmune etiology. We recently showed that SOCS3 deletion in T Lymphocytes suppresses the development of chronic ocular inflammation by up-regulating CTLA-4 and inducing the expansion of regulatory T cells. In ongoing studies: (i) Successfully treated uveitis in mice by topical administration of eye drops formulated with membrane-penetrating SOCS mimetics that specifically target the Janus kinases, JAK1 and JAK2. We also showed that SOCS1 antagonists can be useful in suppressing ocular HSV-1 infection and mitigating herpetic stromal keratitis. (ii) Using transgenic rats that over-express SOCS1 in the retina and mice with targeted deletion of SOCS1 in the retina to further elucidate the role of SOCS1 and SOCS3 in ocular diseases.